Leveraging nanotechnology and skin delivery to drive selective immune tolerance for Multiple Sclerosis

Multiple sclerosis (MS) is an autoimmune disease that develops when the immune system loses tolerance for
myelin in the sheath wrapping axons of the central nervous system (CNS). Damage to the myelin sheath can
result in paralysis, vision impairment, and other neurological complications that significantly diminishes MS
patient quality of life. There is no cure and many MS therapies also eliminate beneficial immunity. One
experimental strategy to specifically counter autoimmunity is the generation of regulatory cell types, such as
regulatory T cells (TREGS). The goal of such approaches is to selectively suppress the inflammatory T and B cells
that are overactive and target myelin through cytotoxic pathways or antibody generation, respectively.
Generation of antigen-specific TREGS and tolerance that counter autoimmunity could provide long-lasting
treatments, while preserving protective immunity. A new idea to promote TREGS is suppression of toll-like receptor
(TLR) signaling. TLRs regulate a power set of pathways that regulate immunity and evolved to detect the
pathogens associated molecular patterns to initiate inflammation and eliminate dangerous pathogens. While
TLRs are well known for their role in pathogen detection, surprising new studies show TLRs are also over-active
during autoimmunity. To harness TLR signaling, the Jewell lab developed a nanotechnology platform where a
regulatory TLR ligand (GpG) is synthesized with myelin self-antigen (MOG) to ensure immune cells receive both
the signals to promote myelin-specific TREGS. Since these nanomaterials – termed immune polyelectrolyte
multilayers (iPEMs) – are built entirely from the immune signals, they display the cues at a high density to potently
modulate immune function. Administration of the iPEMs containing GpG and MOG prevents disease-associated
paralysis in the experimental autoimmune encephalomyelitis (EAE) mouse model of MS.
While promising, these effects were transient, and required multiple, high doses of iPEM injections. To overcome
these challenges, I will develop microneedle arrays (MNAs) to deliver iPEMs built from myelin self- antigen and
regulatory TLR ligands directly to the skin. MNAs are small patches (~1 cm dia.) with polymer needles several
hundred microns in length, designed to target the immune-rich layers in skin. Skin is our largest immunological
organ and contains a high density of immune cells, with specialized phenotypes that are constantly surveying
the skin for foreign pathogens. Recent evidence indicates that some of these immune cells have a unique ability
to promote TREGS in vivo, which were then able to suppress symptoms of paralysis in a common mouse model
of MS. These exciting and recent results suggest that if the tolerance biased immune cells in skin could be
harnessed through their TLR signaling pathways, they may be directed towards a tolerogenic phenotype.
The central hypothesis of this VA CDA-2 proposal is that tolerogenic iPEMs delivered through MNAs will drive
tolerogenic phenotypes in skin-resident antigen-presenting cells that will migrate to draining lymph nodes (LNs)
and instruct T cells toward a TREG phenotype that restrains autoimmunity in a mouse model of MS. To test this
hypothesis, I have designed three specific aims to: 1) assemble iPEM coatings on MNAs and predict their efficacy
in vitro, 2) deliver iPEMs to skin using MNAs to test efficacy and specificity in mouse models of MS, and 3) test
the role of TREGS in promoting efficacy of iPEM coated MNAs and investigate tolerance biomarkers in skin-
draining LNs. This approach will provide two unique opportunities to address both disease and quality of life
issues facing Veterans and their families. First, leveraging the unique immune environment in skin to achieve
antigen-specific tolerance for MS could improve therapeutic efficacy and specificity. Second, MNAs can be
applied independently by MS patients with motor deficits, which would improve independence and compliance.
Collectively, achieving these goals would elevate Veteran MS patient quality of life.

Public health relevance
Myelin protects and amplifies the signals in our brain and spinal cord. Multiple sclerosis (MS) develops when the immune system attacks this myelin, resulting in damage and symptoms like motor and vision loss. MS is prevalent in women and Veterans, who have no curative treatment options and many treatments leave patients vulnerable to infection. These life-long treatments often require injections that limit independence and diminish quality of life. The goal of this project is the development of therapies that specifically counter the attack against myelin, while leaving healthy immunity intact. This will be achieved by engineering therapeutics that precisely promote regulatory immune cells to deactivate the cells that attack myelin. The research will leverage nanotechnology for the assembly and delivery of these therapeutics to skin, where immune cells are dense and were recently shown to regulate autoimmunity. This approach could impact Veterans quality-of-life by providing an effective therapy, without side effects, that is easily and independently applied to skin as a small patch.